Troponin Biosensor for Early Detection and Real-time Monitoring of Myocardial Infarction

Project Summary
Cardiovascular disease (CVD) is the leading cause of death for people in most racial and ethnic groups in the
United States. Acute Myocardial Infarction (AMI) (also called heart attack) is the top cause of death in CVD.
Early detection of AMI translates to earlier intervention and improves survival rates. When cardiac myocytes are
damaged, cardiac troponin (cTn), a component of the heart muscle, is released into circulation. Dynamic and
incremental elevation of blood cTn levels is indicative of an on-going event of heart injury with acute
cardiomyocyte damage. Thus, blood cTn level is routinely measured with commercial cTn immunoassays in
patients suspected of having AMI. However, current cTn immunoassays are limited in sensitivity and speed.
Since two antibodies are used in the current cTn immunoassays (one as the capture and another as the detection
agents), current cTn immunoassays require multiple step reactions with limited sensitivity. Additionally, the
assays are not performed in real time and typically take about 30 mins to get results that could miss the early
rises in cTn levels or its rate of change thus delaying diagnosis. EZ-Lab, in collaborations with investigators at
Oakland Univ., Wayne State Univ., and Univ. of Missouri-Columbia, proposes to develop a novel cTn biosensor
that allows highly sensitive (pg/ml) and real-time detection of cTn based on our years of research and
innovations in 1) uniquely designed peptide mimotope biosensing interface for label-free affinity based
electrochemical biosensor; 2) miniaturized, low cost and real-time electrochemical sensor platform. In sharp
contrast to current cTn immunoassays using two antibodies, we successfully demonstrated that peptide
mimotopes, in lieu of antibodies, when immobilized on the surface via self-assemble monolayer (SAM) can
significantly reduce the structural variability, retain biological activity, and minimize or eliminate non-specific
adsorption from interfering proteins and provide real-time, highly sensitive and selective detection of protein
antigens in human serum samples. To advance this novel peptide mimotope biosensing technology for early
detection and monitoring of AMI for clinical applications, we will rationally design peptides to form robust cTn
biosensing interface for electrochemical cTn sensors allowing one step and real-time detection of cTn in human
serum and blood samples with three research Aims: 1. Develop a highly sensitive peptide sensing interface
for detection of cTn; 2. Validate peptide SAM based cTn biosensor analytical performance using human
serum and blood samples; 3. Real-time cTn sensing in blood sample. The proposed peptide mimotope cTn
biosensor is expected to be highly sensitive and quantitative, faster than current cTn immunoassays used in the
clinics, allowing for early diagnosis of AMI at significantly lower cost for quantifying cTn biomarkers in real world
clinical samples. It is expected that our easy-to-use cTn biosensor can be used to monitor patients’ cardiac
injury status such as by emergency medical service team to obtain the critical data on cardiac injury or AMI from
the patients instantly to help develop urgent and life-saving treatment and management plan.

Public health relevance
Project Narrative Cardiovascular disease (CVD) is the leading cause of death in the United States and worldwide with myocardial infarction (AMI) (also called heart attack) as the top cause of death in CVD. Cardiac troponin (cTn) is a clinically proven biomarker for AMI diagnosis, and blood cTn level is routinely measured with commercial immunoassays for patients suspected of having AMI. However, current cTn immunoassays used in clinics are limited in sensitivity and speed, thus, in this proposal, we will address the gap in the cTn detection fields to develop a highly sensitive and real-time cTn electrochemical biosensor using rationally designed functional peptide mimotopes coupled with electrochemical transducers to allow the measurement of minute quantities of cTn at the onset of myocardial injury, and to provide rapid, real-time and dynamic data on cTn release at the time of onset and during progress of heart injury for timely and accurate diagnosis of AMI to improve treatments and help save lives.